Tuft cell effector functions in the small intestine

Project Summary/Abstract
Helminths, allergens, and certain protists all stimulate a type 2 immune response and contribute significantly to
the global disease burden. Currently, more than 1 billion individuals worldwide are infected with helminths, and
the rising incidence of allergic disease represents an emerging epidemic. The sensing and signaling events
that initiate type 2 immunity remain poorly understood, but in the small intestine they require epithelial tuft cells.
Tuft cells regulate a tuft-ILC2 circuit in which tuft cell-derived IL-25 activates group 2 innate lymphoid cells
(ILC2s) in the underlying tissue. ILC2s secrete the canonical type 2 cytokines IL-5, -9, and -13, which
collectively drive hallmarks of type 2 immunity, such as eosinophilia and tissue remodeling. IL-13 also
promotes a feed-forward response by inducing tuft and goblet cell hyperplasia. The immune function of tuft
cells requires a chemosensory pathway and recent studies identified the microbial metabolite succinate as an
intestinal tuft cell ligand that is sufficient to activate the tuft-ILC2 circuit. Tuft cells therefore act as IL-25-
secreting immune sentinels, but several lines of evidence support the central hypothesis of this proposal that
additional tuft cell effector functions must exist: (1) Tuft cells express IL-25 constitutively, but the feed-forward
tuft-ILC2 circuit is only activated in the presence of helminths or protists, suggesting additional activating
signals; (2) the initiation of tuft cell hyperplasia after immune sensing has occurred suggests tuft cells
contribute to the effector stages of type 2 immunity; and (3) helminth clearance is more delayed in tuft cell-
deficient mice than in mice that lack only IL-25. The goal of this proposal is therefore to discover and
characterize novel tuft cell effector functions in the small intestine. Using a combination of innovative in vitro
assays and in vivo helminth infection of genetically modified mouse strains, we propose to test the regulation
and function of tuft cell-derived IL-25, leukotriene C4, and acetylcholine. These studies should identify novel
targets for therapeutic intervention in both helminth infection and allergic disease.

Public health relevance
Project Narrative Parasitic worms, allergens, and some protists all trigger a “type 2” immune response, but we do not yet fully understand the underlying mechanisms of immune sensing and regulation. More than 1 billion individuals are currently infected with worms, and the incidence of allergies is rising worldwide. By studying the role of epithelial tuft cells in type 2 immunity, we hope to discover novel targets for therapeutic intervention in helminth infection and allergy.